NonInvasive Virtual Biopsy for Determining Bone Turnover in Chronic Kidney Disease

PROJECT SUMMARY / ABSTRACT
Extremes of bone turnover are common in patients with chronic kidney disease (CKD), a population with
exceptionally high fracture risk. Medical management of fracture risk in CKD requires assessment of bone
turnover. Bone turnover assessment is important because either high or low bone turnover can lead to low bone
mass and fracture risk, but treatment in these two bone turnover scenarios are diametrically opposite. There are
now FDA approved medications that can either decrease (e.g. bisphosphonates) or increase (e.g. teriparatide)
bone turnover, but these must be used carefully in CKD to avoid exacerbating fracture risk.
The gold standard measurement of bone turnover in CKD requires bone biopsy and histomorphometry, which
is invasive, expensive, and not widely available. While blood biomarkers can give insights to bone turnover in
the general population, these biomarkers are cleared from the body by the kidneys, and therefore are uniformly
elevated and disassociated with bone turnover rates in CKD patients. Clinically available bone imaging
modalities quantify bone mass, but cannot determine bone turnover rates. Thus, a particularly important clinical
need is to identify novel methods to assess bone turnover rates non-invasively in CKD patients. Such innovations
would immediately impact clinical practice to prevent fractures in CKD.
High resolution peripheral quantitative computed tomography (HR-pQCT) can image bone in fine detail with
low radiation dose. Cross-sectional and longitudinal HR-pQCT studies typically characterize bone density and
microstructure, but like other bone imaging modalities, do not quantify bone turnover. We propose non-invasive
‘virtual bone biopsy’ for assessment of CKD turnover metrics through the application of time-lapse HR-pQCT. In
time-lapse HR-pQCT, data obtained serially over a period of interest are processed to identify and quantify
specific areas of new bone formation and resorption, enabling the direct measurement of bone formation rate,
bone resorption rate, and total bone turnover. These measurements can be obtained for the integral volume or
within trabecular or cortical compartments.
We aim to compare time-lapse HR-pQCT to the gold-standard, tetracycline labeled histomorphometry by
biopsy, and to determine the sensitivity and specificity of time-lapse HR-pQCT for assessment of turnover status
in a CKD population. In addition, we propose to obtain repeat HR-pQCT time-lapse data longitudinally to
determine whether time-lapse HR-pQCT can monitor changes in turnover in response to therapy. The data
generated here will be used to design follow-on clinical trials testing whether treatment guided by time-lapse HR-
pQCT can decrease fracture risk compared to usual care in CKD patients.

Public health relevance
PROJECT NARRATIVE Persons with chronic kidney disease (CKD) are at high risk of fracture; however, medical management requires knowing the underlying bone turnover rate, which currently requires invasive, painful, expensive, and inaccessible bone biopsy and histomorphometry. We propose an imaging-based non-invasive ‘virtual bone biopsy’, which applies time-lapse high resolution quantitative computed tomography (HR-pQCT) to identify and quantify specific areas of new bone formation and resorption throughout a volume of bone over time. We aim to validate a novel metric of bone turnover measured by time-lapse HR-pQCT vs. the gold-standard bone turnover measured by bone biopsy, determine the sensitivity and specificity of time-lapse HR-pQCT for assessment of turnover in a CKD population, and determine whether time-lapse HR-pQCT can detect responses to therapy over time in CKD patients.